Filling a Void of Research (FAVOR) Training for Transplant Surgeons

PROJECT SUMMARY/ABSTRACT
The FAVOR T32 titled “Filling a Void of Research Training for Transplant Surgeons” will prepare surgical
residents for translational research careers in abdominal and thoracic transplant surgery. This program will
train and inspire a unique cadre of surgeon-scientists to translate astute observations at the bedside, in the
operating room, and in the clinic into novel hypotheses that can be interrogated through immunology-focused
translational research. This program is uniquely focused, serving a growing need to train the next generation of
transplant surgeon-scientists that can contribute to the burgeoning field of translational and personalized
medicine. FAVOR is structured to reverse the dismal trend resulting in only 1.8% of ASTS trained surgical
fellows successfully competing for NIH-K series awards, despite 76% being motivated to spend more time in
research (Englesbe et al., AJT 2010:10, 191-193; Kirk & Feng, AJT 2011, 11; 191-193). The training includes
core courses in Designing Clinical Research, Statistical Computing and Database Management in Clinical
Research, Scientific Writing, and Biostatistical Methods for Clinical Research. The FAVOR T32 also includes
specialized training electives, which will be tailored to each trainee based on long-term goals and interests. A
small cadre of surgical trainees from within UCSF, all training grant eligible and highly diverse (~40% URM,
50% female), will be selected for FAVOR. We will also invite trainees from other academic institutions by
competitive application for training slots, where trainees will dedicate two full-time years, without significant
clinical responsibilities, towards research education and training. One trainee slot/year will also be eligible to
enroll in a 1-2 year degree course in Clinical/Translational Medicine. Trainees will be prepared to apply their
training to deepen understanding of the immune system, as well as developing new, immune-based
diagnostics, prognostics, therapeutics and clinical approaches that are relevant to surgical procedures and
outcomes. While in the program they will also learn how to develop and draw upon clinical databases that
integrate surgical outcomes with data from pathology and immunology. FAVOR's NIH-funded faculty, with
distinguished track records in immunology and translational research, have been specially selected to inspire
and guide trainees in translational mentored research, with selection of 2 mentors/trainee from each of the
clinical and scientific mentor pools. Post-training career advice and guidance will facilitate placement into
prestigious fellowships and academic faculty positions for FAVOR trainees. The national impact of the FAVOR
program will be realized through the scientific maturation of a trainee group with comprehensive clinical
expertise and outstanding translational science, with the ability to apply translational immunology to benefit
organ transplant recipients.

Public health relevance
PROJECT NARRATIVE The UCSF Department of Surgery's T32 training grant titled “Filling a Void of Research Training for Transplant Surgeons” (FAVOR) will provide two years of funding for in-depth training in translational immunology for 2 surgery residents/year with an interest in transplant surgery, to prepare them for careers as academic transplant surgeons. The goal of the FAVOR T32 is to train and inspire a unique cadre of surgeon-scientists to translate astute observations at the bedside, in the operating room, and in the clinic into novel hypotheses that can be interrogated through immunology-focused translational research.